Administrative Core

ABSTRACT
Administrative Core
The Administrative Core ensures that the core services are of the highest quality and that the core
resources are used efficiently and effectively by UCSD vision researchers. The PI, Core Directors and co-
Directors, Executive Committee and Advisory Committee provide administrative and budgetary oversight
and strategic direction to the 5 cores supported by the UCSD Vision Research Core grant.